NEUROPSYCHOPHARMACOLOGY: MULTIDISCIPLINARY TRAINING

The purpose of this Institutional T32 program is to provide promising young scientists with mentor-based training
in a dynamic, highly collaborative and interactive environment to promote their development as independent
investigators engaged in alcohol research. Highly qualified candidates are competitively selected from a large
applicant pool recruited through advertisements in addiction- and neuroscience-related societies and
publications, referrals from established colleagues in the field of alcohol research and addiction, and from letters
of inquiry resulting from the Training Faculty’s publications and public presentations. A rigorous training program
develops trainees’ skills in (i) identifying important testable hypotheses, (ii) experimental design and conduct, (iii)
data analysis and interpretation, and (iv) scientific communication through written and oral presentation.
Emphasis is placed on career development. Upon admission, trainees complete an Individual Development Plan
(IDP) and Postdoctoral Competencies assessment to generate trainee-mentor discussions of career goals and
benchmarked plans for achieving them. Progress and goals are dynamically reassessed during the training
period. Trainees will receive significant didactic experiences at The Scripps Research Institute (TSRI) and
affiliated institutes to develop expertise in scientific, career skills, mentoring and outreach domains. Program
mentors, TSRI and UCSD career development faculty, and distinguished visiting researchers will engage
trainees individually and in workshops and seminars to enhance scientific knowledge, technical training,
extensive career skills, and professional networks. Extramural individualized courses and workshops are
encouraged and recompensed. Trainees are educated in the responsible conduct of research and in rigor and
reproducibility via extensive faculty-led curricula from the TSRI Career and Postdoctoral Services Office,
contracts with UCSD, the Neurobiology of Addiction Course taught by Program Faculty, and day-to-day input
from mentors and Program Faculty regarding ethical practices in research and society. Mechanisms are in place
to recruit trainees from underrepresented groups; provide education in and promote program values of diversity,
equity and inclusion; and reduce social disparities in the field and science of addiction research. The collaborative
group of 16 Program Faculty is characterized by strong, well-funded programs in alcohol and addiction research
that incorporate multidisciplinary, cutting-edge edge biochemical, morphological, physiological, and behavioral
experimental approaches. This translational training program is associated with the longstanding TSRI P60 ARC
and Pearson Center for Alcoholism and Addiction Research, situated in the rich San Diego-area neuroscience
and addiction community. Trainees can engage in studies spanning from molecular and cellular domains through
neurobiological and circuitry mechanism in whole animals, to clinical studies on the vulnerability to and treatment
of alcohol use disorders. The training program has consistently prepared outstanding young investigators since
1979 for a rapid transition to independent, impactful careers in alcohol research and addiction neuroscience.

Public health relevance
PROJECT NARRATIVE This is a training program to train promising young scientists at the postdoctoral level (post Ph.D.) in molecular, cellular, behavioral and clinical neuropsychopharmacology. Trainees participate in scientific project development, seminars from visiting scientists, a course in neurobiology of addiction, a course in ethical conduct of research, training in rigor and reproducibility, and training in career development for pathways to independence. Established procedures for recruitment to increase diversity in research, evaluation and career development are in place.